A C. Elegans Model of Fanconi Anemia Neurological Syndrome

PROJECT SUMMARY
Fanconi anemia (FA) is a genetic disease characterized by increased risk for bone marrow failure and
cancer, with few therapeutic options. In recent years, central nervous system defects have become
increasingly observed among FA patients. These include early-onset progressive and irreversible
neurological decline. These neurological manifestations have been collectively coined Fanconi Anemia
Neurological Syndrome or FANS. Importantly, the molecular etiology of FANS is unknown.
Recent omics approaches from our laboratory have uncovered mechanistic links between the FA proteins
and the nervous system. Using ChIP-seq, we have discovered that the FANCD2 protein binds to numerous
large neural genes, including genes that function in neuronal differentiation, migration, and cell-cell
adhesion. RNA-seq analysis has also revealed differential expression of many of these genes in FA patient
cells. Importantly, many FANCD2 target genes are genetically linked to neuropsychiatric and
neurodevelopmental disorders such as autism spectrum disorder (ASD), schizophrenia, and intellectual
disability, as well as Alzheimer’s disease and related dementias (AD/RD). Our preliminary findings
suggest a role for the FA pathway in the maintenance of genome stability during neural stem and
progenitor cell expansion during neurogenesis. Defects in this process are highly likely to lead to
nervous system dysfunction across the lifespan, characteristic of FANS.
In this R15 AREA application, we will use the model nematode Caenorhabditis elegans to study the
molecular etiology of FANS. Three specific aims are proposed; In aim 1, we will examine the roles of
orthologs of several FA proteins in nervous system function across the lifespan using behavioral paradigms
linked to neuronal subclasses associated with human neurological disorders. In aim 2, we will generate FA
animals expressing GFP-labeled cholinergic, dopaminergic, GABAergic, and glutamatergic neurons, and
neurons will be analyzed for numerical and structural defects using confocal microscopy. We will also
perform neuron-specific RNA-seq analysis to determine which genes/pathways are differentially expressed
between wild-type and FA transgenic animals. In aim 3, to gain insights into the mechanisms by which the
FA pathway maintains genome stability during neurogenesis, we will use PacBio long-read sequencing to
examine the role of the FA pathway in the suppression of genomic structural variation.
For FANS and AD/RD, there is an urgent need to identify molecular targets to prevent, delay, and/or
ameliorate clinical manifestations. Our studies could lead to the identification of new molecular
targets linked to FANS and AD/RD, and open new avenues of potential therapeutic intervention.

Public health relevance
NARRATIVE Fanconi anemia (FA) is a genetic disease characterized by increased risk for bone marrow failure and cancer, with limited therapeutic options. In recent years, central nervous system defects, including early- onset progressive and irreversible neurological decline, have become increasingly observed among FA patients. The major goal of this R15 research proposal is to begin to define the role of the FA pathway in ensuring efficient nervous system development and function and in mitigating accelerated neuronal decline.